Broad-spectrum HIV gene editing strategies in peripheral and brain reservoirs

Project Summary/Abstract
Combination antiretroviral therapy (cART) is effective at reducing viral load and suppressing HIV-1 infection,
however, there still is no cure for HIV-1 disease. This is due in part to the formation of latently infected cells
harboring integrated proviruses in tissue and cell reservoirs. Clustered regularly interspaced palindromic repeats
(CRISPR) gene editing has shown promise as an HIV cure strategy. All Cas enzymes in use today initiate binding
by recognizing a protospacer adjacent motif (PAM) followed by the complementarity between guide RNA (gRNA)
and target DNA to induce DNA cleavage. Subsequent double-strand break repair by endogenous cellular
processes has been shown to result in a non-random mutational distribution dictated by protospacer and flanking
sequence context. Furthermore, natural genetic variation within integrated proviral sequences has been shown
to decrease the CRISPR-mediated editing efficiency which is critically dependent for efficacy of the gRNA
selection process. The past funding period, we have designed a patented computational pipeline to select broad-
spectrum spCas9 gRNAs that account for HIV sequence variation within and between large numbers of
individuals and that have no off-target effect using predictive algorithms or functional assays. Preliminary data
presented here shows gRNAs have efficacy in other tissue compartments (brain) and across subtypes. In
addition to these gRNA design advances, the team also showed major advancements in delivery and
effectiveness in small animal studies and non-human primate studies. In order to better harness the utility of
CRISPR/Cas gene editing, this project will utilize novel high-throughput biologic assays combined with state-of-
the art computational biology to expand what is known about how novel Cas enzymes edit the DNA target in
vitro and test HIV-1-infected patient samples ex vivo and in vivo to optimize treatment strategy (Cas:gRNA
combination) selection to account for HIV sequence variation within and across tissue compartments (periphery
vs brain) and subtypes. Novel resources like the Multiple Lentiviral Expression System (MuLE) and the
Mammalian Synthetic Cellular Recorder Integrating Biological Events (mSCRIBE) will be leveraged to study Cas
enzymology and HIV-1 reactivation at the single-cell level. We hypothesize that, Cas:gRNA targeting will induce
safe and reproducible editing outcomes that are predictablly based on the enzyme, target, and surrounding
nucleotide sequence. To interrogate this hypothesis, three Specific Aims will be used: (i) develop a generic model
of Cas:gRNA combination repair outcomes, (ii) identify functional impact of Cas:gRNA pairs using molecular
recorders, and (iii) ex vivo and in vivo testing of combined Cas:gRNA pairs on HIV. These Aims will extend the
knowledge of CRIPSR editing technologies for all fields of biology using the HIV platform. It will do this in cells
important for HIV research in the periphery and the CNS (T, monocyte, microglia) and under different activation
states. For HIV specifically, it will extend Cas:gRNA design into other tissues and between subtypes to develop
a highly significant and innovative approach to target the HIV-1 quasispecies. This will result in a highly effective
treatment strategy for using CRISPR gene-editing as a potential cure for HIV infection and disease.

Public health relevance
NARRATIVE Current antiretroviral therapy has failed to eradicate HIV-1, partly due to the persistence of viral reservoirs including CD4+ T lymphocytes, cells of the monocyte-macrophage lineage, and other central nervous system cells. We propose to use state-of-the-art gene editing technology to extend the field’s general knowledge and specifically improve our ability to develop broad- spectrum CRISPR-based treatments to target the vast spectrum of HIV quasispecies as an important next step in the development of strategies to potentially cure for HIV disease.